Build to LEAD – Building partnerships to Link the Exposome to Autoimmune Disease (Admin Supp)

SUMMARY
We are requesting an Administrative Supplement for 1R21AR084042 “Build to LEAD – Building partnerships to
Link the Exposome to Autoimmune Disease”. The Administrative Supplement studies are within the scope of the
active parent grant, which is focused on establishing collaborative teams to participate in the Exposome in
Autoimmune Diseases Collaborating Teams (EXACT) Network. All EXACT Network sites will study how
environmental exposures influence autoimmune disease susceptibility, onset and outcomes. This Administrative
Supplement will provide an opportunity to establish additional collaborations, expand the Autoimmune Exposome
Summits proposed in the parent grant and expand harmonization of exposome data collection to all members of
the EXACT Network. The Administrative Supplement has three Specific Aims. Specific Aim 1 proposes to
establish additional collaborations with experts in environmental exposures and to increase the involvement of
the expert consultants in the parent grant. Specific Aim 2 proposes to expand the Autoimmune Exposome
Summits and related working and advisory groups to include additional key stakeholders with expertise beyond
the parent grant but critical for the EXACT Network. This could include experts in pediatric autoimmune diseases
and social determinants of health. Specific Aim 3 proposes to expand the harmonization of exposome data
collection to the EXACT Network. This will include a landscape analysis of exposome data across the network,
identification and selection of optimal processing protocols for exposure-associated biospecimens and defining
shared priorities for existing data to be harmonized in future EXACT Network studies. Notably, all of the proposed
work will be done in consultation with NIH and the EXACT Network and will be foundational for future EXACT
Network studies. The proposed work is within the scope of the parent award as it focuses on establishing
collaborative teams for studying the role of the exposome in the development and progression of autoimmune
disease.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it is focused on establishing collaborative teams to study how environmental exposures influence the development and progression of autoimmune diseases. Understanding the role of environmental exposures is important for developing therapeutic approaches to treat and prevent autoimmune diseases.